THE CLONAL EVOLUTION OF BREAST CANCER

Genetic linkage analysis will be performed to identify kindreds from breast cancer families in which breast cancer is linked to the BRCA1 locus on chromosome 17q.